Elucidating the Cell-Type Specific Neuroprotective Mechanisms in the APOE3 Christchurch Mutation in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s Disease (AD) is the most prevalent form of late-onset dementia, known for the presence of
amyloid plaques and neurofibrillary tangles of hyperphosphorylated tau. There is a portion of patients with AD
who develop symptoms before the age of 65, known as early-onset autosomal dominant AD (ADAD), caused by
mutations in the presenilin-1 (PSEN1) gene. A specific kindred of these patients was identified for having PSEN1
E280A mutations in Colombia, leading to mild cognitive impairment in their early 40s and dementia by late 40s.
One patient from this kindred interestingly did not develop any memory deficits until she was in her 70s.
Postmortem analyses showed that in addition to her PSEN1 E280A mutation, she also was homozygous for a
mutation in her APOE3 gene, known as the Christchurch mutation (APOE3cc). Apolipoprotein E (APOE) is a
lipid transporter that is expressed by astrocytes and microglia in the central nervous system and is the most
common risk factor for AD. Ultimately, a better understanding of how this mutation yields resilience against ADAD
could be a promising therapeutic target for AD.
First, we created a mouse model of human APOE3cc to replicate the patient’s rare homozygous mutation
in mice. We leveraged single nuclei RNA sequencing (snRNAseq) to elucidate which cell types could be
responsible for APOE3cc’s resilience. The snRNAseq data implicated both microglia and astrocytes as
regulators of APOE3cc’s neuroprotection. In microglia, our data showed that ApoEcc/cc+P301S mice significantly
downregulated several interferon genes. High levels of type-I interferons in the CNS, present in both aging and
neurodegeneration, have been associated with detrimental effects on cognition. In astrocytes, ApoEcc/cc+P301S
mice showed reprogramming of mitochondrial and antioxidant genes. Oxidative stress and neurodegeneration
are inextricably linked, and having increased antioxidant genes could explain downstream resiliency in the
patient. Additionally, previous studies have linked oxidative stress to activation of the interferon pathway. I
hypothesize that the combination of microglial interferon suppression and astrocytic antioxidant
reprogramming protect against tau-mediated dysfunction in the ApoE3cc/cc mice. To test this hypothesis,
we aim to determine the following: 1) determine the relationship of the interferon response in ApoE3cc/cc microglia
to neuronal health and neurite outgrowth. 2) analyze the ApoE3cc/cc astrocytic mitochondrial, antioxidant, and
metabolic response to tauopathy. Both aims will utilize a combined in vivo and in vitro approach.

Public health relevance
PROJECT NARRATIVE Alzheimer’s Disease is the most prevalent form of late-onset dementia, but patients with presenilin-1 mutations can develop early-onset dementia in their 40s. A patient with a mutation in APOE3 (APOE3cc) didn’t develop dementia until her 70s, despite having a presenilin-1 mutation. This project will dissect the cell type-specific molecular mechanisms governing the neuroprotective effect regulated by the APOE3cc mutation.